Integrating smartphone photography for trachoma, smartphone visual acuity assessment, and mobile autorefraction to enhance community-based public health monitoring

The World Health Organization (WHO) aims to eliminate trachoma, the world's leading infectious cause of
blindness. To determine if trachoma treatment is needed in an area, the WHO recommends eye examinations
on a population-based sample of children by personnel certified in trachoma grading. The WHO's successful
trachoma elimination campaign has created a situation in which some areas have too many to trachoma cases
to declare elimination but too few trachoma cases to certify trachoma graders. Adopting smartphone-based
trachoma telemedicine addresses this issue by allowing workers with little clinical experience to perform
trachoma photo-surveys for remote trachoma diagnoses. However, the WHO's current data collection platform
for trachoma surveys, Tropical Data, does not currently support ocular photography. We propose here to
integrate smartphone photography with Tropical Data and add functionality that will transform it into a more
user-friendly, open access suite of smartphone-based survey modules. This would enhance flexibility and
facilitate broader health surveys that can be used to better target limited health resources.
This first part of the study aims to develop and refine the hardware and software necessary to integrate
smartphone conjunctival photography into the Tropical Data platform, and to assess the feasibility of the
resulting product in remote community-based settings in Peru. First, modules for photography, visual acuity
assessment, autorefraction, sample collection, and user-defined questionnaires will be added to the existing
Tropical Data application. Second, the impact of varying smartphone models and/or ambient lighting will be
assessed for each module. Third, the updated mobile application will be tested in a small number of villages to
determine the feasibility of testing multiple modules per child.
The second part of the study validates the components of the smartphone-based system when used in three
different field locations in Peru (e.g., jungle, mountains, desert). We will examine the sensitivity and specificity
of smartphone photography relative to certified human graders, smartphone visual acuity relative to standard
ETDRS visual acuity, and autorefraction relative to human refraction, and hypothesize that these metrics will
be superior to pre-defined minimally acceptable criteria.
The UCSF Proctor Foundation and Cayetano University in Peru will collaborate to achieve these goals. We
will work in close cooperation with the WHO and Tropical Data, who will be actively engaged in this research
throughout development and testing. This research has great potential for wide dissemination and positive
impact on health.

Public health relevance
PROJECT NARRATIVE Trachoma is the leading infectious cause of blindness in the world. This project aims to develop a mobile software application to enhance trachoma monitoring activities by allowing eye photography and integration of visual acuity and refractive error assessment. The mobile application will be field-tested and validated in diverse settings in Peru to ensure broad generalizability.